Natural History of Ocular GVHD

There are no data yet to report on this protocol. To date, 20 subjects have been enrolled, with the first participant nearing the two-year exam following autologous stem cell transplant. Several patients have been advised to initiate topical cyclosporine eye drops in response to changes in ocular indicators (symptoms, drop in Schirmers tear production, or worsening of surface dryness). Our team hopes to correlate changes in patient symptoms and exam findings with changes in the tear fluid biomarkers. We anticipate receiving the results of the first processing of tear film biomarker, performed by our non-NIH collaborators, in the coming month, and anticipate having a summary of findings by the next reporting period.